Molecular studies of neural histone monoaminylation in normal and aberrant brain plasticity

Major depressive disorder (MDD), among other mood disorders, is a highly heterogeneous, debilitating illness
that affects millions of individuals worldwide; however, disruptions in brain function that precipitate MDD are
poorly understood, and current treatments have limited efficacy. Despite being serendipitously discovered
more than 60 years ago, monoamine associated antidepressants (ADs; e.g., SSRIs) remain the first line of
therapy for many with MDD, yet long delays between initiation of treatment and symptomatic alleviation,
as well as low remission rates, have encouraged further investigations in an attempt to identify more
direct therapeutic targets. Serotonin, in particular, is thought to play a critical role in neuronal plasticity, with
alterations in its signaling implicated in both the development and treatment of MDD. Although vesicular
packaging of serotonin is essential for neurotransmission, recent data, including from our own laboratory, have
demonstrated the additional presence of extravesicular monoamines in the nucleus of both monoaminergic
neurons, as well as in neurons from monoaminergic projection regions; it has remained unclear, however,
whether nuclear serotonin may play roles independent of neurotransmission. Serotonin has previously been
shown to form covalent bonds with certain proteins via transamidation by the tissue Transglutaminase 2
enzyme, a process known as serotonylation. Our laboratory recently identified and fully characterized histone
proteins (specifically histone H3 glutamine 5 in combination with lysine 4 tri-methylation; H3K4me3Q5ser) as
novel substrates for serotonylation in vivo. Furthermore, we recently found that H3K4me3Q5ser is significantly
altered in its expression in both postmortem dorsal raphe nucleus (DRN) of human subjects diagnosed with
MDD, and in an etiologically relevant rodent model of human depression (chronic social defeat stress)–
phenomena that are completely reversed by therapeutically effective chronic AD treatments. Thus, we
hypothesize that histone serotonylation likely establishes important patterns of neuronal gene expression in
brain that are necessary for normal transcription, a molecular mechanism that if perturbed by chronic stress (or
other manipulations that alter serotonin dynamics) may lead to aberrant plasticity and vulnerability to
depressive- and/or anxiety-like behaviors. Such a mechanism may also explain the delayed efficacy of SSRI
ADs. We therefore plan to assess these possibilities in the following Aims: 1) perform sex and cell-type specific
epigenomic analyses of H3K4me3Q5ser in normal vs. stressed brain, both basally and in the context of SSRIs;
2) assess the transcriptional and behavioral impacts of cell-type specific manipulations of histone H3
serotonylation on stress-induced behaviors; and 3) explore novel mechanistic links between histone
serotonylation and pre-initiation complex formation in vulnerable neurons following chronic stress. This work
promises to provide critical insights into how serotonin, independently from neurotransmission, contributes to
adulthood neuronal plasticity, as well as how it may influence on the onset of MDD/stress related phenotypes.

Public health relevance
Human major depressive disorder (MDD)–along with related mood and traumatic stress disorders–is a chronic, remitting syndrome that affects millions of individuals worldwide; however, few advances in the treatment of depression have been made since the discovery of tricyclic and monoamine oxidase inhibitor antidepressants over six decades ago. Furthermore, little remains known concerning the precise molecular mechanisms mediating MDD/stress vulnerability or individual responsiveness to antidepressants. This proposal thus aims to comprehensively examine a novel molecular mechanism recently implicated in MDD vulnerability–i.e., histone H3 serotonylation in brain, a protein modification discovered and biochemically characterized by our laboratory–with respect to its contributions to cell-type specific gene expression patterns in neurons in the context of both normal and deleterious life experiences (e.g., chronic stress), as well as its potential roles in the mediation of depression susceptibility and/or antidepressant efficacy.